Type I Interferon Dysregulation in Down Syndrome

Project Summary Type I interferons (IFN-Is) are potent cytokines, playing a key role in the antiviral response. However, they can also be detrimental to human health. Type I interferonpathies are disorders known to be caused by IFN-I dysregulation. Mendelian type I interferonopathies, such as Aicardi–Goutières syndrome (AGS), illustrate how the dysregulation of IFN activity can lead to neurological and autoimmune diseases. Down syndrome (DS) is the most common genetic cause of intellectual and developmental disabilities in children and young adults, affecting over 200,000 individuals in the US. In addition to cognitive problems, individuals with DS often have cardiac and gastrointestinal abnormalities. They also have various immunity- related defects, ranging from increased susceptibility to an array of infectious diseases to autoimmunity. Unfortunately, the exact molecular mechanism underlying these immune defects has yet to be elucidated. In most cases, DS is caused by the presence of an extra chromosome 21. Interestingly, the 200 or so genes present on this autosome include those encoding the type I interferon receptors (IFNAR1 and IFNAR2), suggesting a possible effect of gene dosage. Given that some type I interferonopathies are driven by minute increases in the levels of IFN-I cytokines, we decided to investigate the regulation of IFN-I in individuals with DS. This proposal is built around the hypothesis that the relative levels of IFNAR1 and IFNAR2 are the essential factors controlling the responsiveness to and duration of IFN-I responses in a cell type-specific manner in individuals with DS, thereby contributing to the disease. We plan to test this hypothesis, by studying DS patients in vitro, ex vivo, and in vivo at the molecular, immunological, neurological and clinical levels, to assess the functional effects of the increases in the dosage of these genes on the regulation of the IFN pathway in humans. A deeper understanding of the molecular regulation of IFN-I in DS will provide us with greater insight into the pathophysiology of DS and pave the way for the possible use of inhibitors to alleviate the persistent inflammatory disorders associated with DS.

Public health relevance
Project Narrative Down syndrome is caused principally by chromosome 21 trisomy, resulting in extra copies of the genes encoding the interferon (IFN-I) receptors, IFNAR1 and IFNAR2. Signaling through these IFN-I receptors initiates the highly potent antiviral and inflammatory functions of the IFN-I response. This study aims to investigate the effects of the presence of additional copies of IFNAR1 and IFNAR2 in Down syndrome, on the IFN-I response, and the contribution of these extra gene copies to the pathogenesis of Down syndrome.